Pre- and Postdoctoral Training in Toxicology

PROJECT SUMMARY
This training grant proposal requests support for 8 predoctoral and 3 postdoctoral trainees in the Curriculum in
Toxicology (CiT) at the University of North Carolina-Chapel Hill (UNC-CH). The proposed training program brings
together a highly interactive and productive faculty of basic scientists, physician scientists, and public health
researchers from the Schools of Medicine, Public Health, and Pharmacy at UNC-CH, plus outstanding
researchers and mentors from the U.S. EPA and NIEHS in Research Triangle Park. The training program faculty
includes 43 investigators with proven research records in environmental health and toxicology. The CiT focuses
on several areas of training, such as (1) mechanisms of toxic injury by environmental agents, (2) relevance to
disease pathogenesis of exposure to environmental pollutants, (3) systems of protection against cellular
damage, and (4) influence of genetic variability on outcomes of toxicant exposures. This collaborative training
program integrates resources and training opportunities available at UNC-CH and within local government
agencies (NIEHS and EPA) and aims to provide the best scientific research and mentoring environment
necessary to train future investigators. Our overall mission is to train predoctoral and postdoctoral trainees to
integrate basic toxicology with next-generation research tools to advance environmental health and toxicology
knowledge in the 21st century. Consequently, our research training focuses on providing predoctoral and
postdoctoral trainees the environment, infrastructure, and resources to conduct interdisciplinary cross-cutting
research in environmental toxicology, systems toxicology/biomarkers, research translation, and animal models
of human diseases. CiT trainees have gone on to productive careers in academia, government, and industry. In
order to maintain this successful training program, we continuously update our training approaches, incorporating
feedback from our external advisory committee and other forms of training program evaluation. During the
previous funding period, we expanded measures to enhance program cohesiveness, increased opportunities
and formal training in grant writing, recruited faculty who can enhance training opportunities in emerging fields
in Toxicology and Environmental Health, and increased training opportunities in professional skills. The CiT
continues to have outstanding didactic instruction, excellent training and mentoring oversight, unparalleled
resources, and a superb environment to support the proposed training. As outlined in this application, our
previous record demonstrates that the outstanding new scientists we train will excel at interdisciplinary
approaches that result in the mechanistic understanding and translation of how the environment influences
human disease.

Public health relevance
PROJECT NARRATIVE This interdisciplinary training program is designed to provide the necessary resources, infrastructure, and research opportunities for predoctoral and postdoctoral trainees interested in toxicology and environmental health effects on human diseases. The goal of the Curriculum in Toxicology at UNC-CH is to train new scientists that are able to enhance our understanding of how the environment affects human disease.